MECHANISMS OF REGULATION OF CEREBRAL VASOMOTOR REACTIVITY

The primary objective of this protocol is to delineate the mechanism(s) for the vasodilator response to hypercapnia in normal subjects and in subjects with stroke risk factors.